In situ imaging of the aging-induced structural and stoichiometric degradation of the nuclear pore complex and nuclear periphery

PROJECT SUMMARY
Ultrastructural molecular/sub-molecular level aging-induced degradation in cellular assemblies makes them dys-
functional leading to cellular dysfunction that causes and exacerbates the aging-related problems. However, no
investigation has been carried out to explore such degradations due to the lack of imaging modalities that are sen-
sitive enough to capture the sub-molecular level features inside the cells in situ. One such assembly is the Nuclear
Pore complex which creates a conduit in the nuclear membrane essential for cytoplasm-nucleoplasm trafficking,
chromatin silencing, transcriptional control, and other vital cellular processes. NPC is a highly dynamic assembly
formed of extremely long-lived aging-affected proteins, whose composition, structure, and function deteriorate with
aging. This deterioration then negatively impacts their critical cellular functions, causing a decay in the health
and function of the cells, which is especially relevant for non-dividing, non-rejuvenating, and aging-prone cells
like neurons, thereby contributing to neurodegeneration. Cryo-focused ion beam milling and electron tomography
(cryo-FIB-ET) imaging is a novel and emerging imaging modality that allows us to peek into the cells at the
sub-molecular level, enabling in situ structural biology. Complementing cryo-FIB-ET imaging, single-molecule
imaging can be used to explore the identification of the building blocks of massive cellular assemblies and also
the molecular mechanism of its assembly. Using cryo-FIB-ET, Dr. Singh recently identified the in situ
architecture of the NPC (Cell (2022)). He has also contributed to the development and application of
cryo-FIB-ET imaging with contributions to 4 publications in his postdoc. During Ph.D., Dr. Singh trained in
single-molecule imaging to study the molecular mechanism of CRISPR enzymes and T4-bacteriophage motor with
11 publications, including 6 as first/co-first. By leveraging his dual expertise in cryo-FIB-ET and single-molecule
imaging and a broad collaboration effort within UCSD, around UCSD and with his collaborator and co-mentor at
Rockfeller, Dr. Singh will determine:
• The structures and isoforms of aged NPCs to map its aging-accumulated degradations (K99 phase).
• Aging-induced changes in composition of NPC and its building blocks (K99 to R00 transition).
• The assembly process of the NPC to understand how aging affects it (R00 phase).
Dr. Singh will receive the needed training under the mentorship of Drs. Elizabeth Villa and Michael Rout.
These mentors have demonstrated excellence in research leadership and have trained multiple trainees who have
transitioned to independent fulfilling careers in sciences. In addition, an excellent team of collaborators and
advisory committee (Drs. Andrej Sali, Nan Hao, Elizabeth Villa, Michael Rout) has been assembled to assist Dr.
Singh’s research and provide additional training and career support through the K99-R00 phase. The R00 Award
phase will set the foundation for Dr. Singh’s long-term career goals of establishing a rigorous research program
that seeks to merge two powerful imaging modalities to understand the cellular level changes caused by aging at
the molecular level.

Public health relevance
NARRATIVE The Nuclear Pore Complex (NPC) is a large megadalton cellular assembly composed of ∼550 proteins, that degrades structurally and compositionally with age, causing severe difficulties with cellular processes. The elusive ultrastructural and compositional degradation of NPC and their building components will be imaged using a combination of cryo-Focused Ion Beam milling-Electron Tomography (cryo-FIB-ET) and single-molecule imaging. With training from diverse group of mentors/advisors, this proposal will lay the groundwork for a new research program that will use these cutting-edge imaging modalities to map important ultrastructural/compositional cellular alterations caused by aging.